Bayesian Modeling of Mass-Spec Proteomics Data to Advance Studies of the Genetic Regulation of Proteins

PROJECT SUMMARY / ABSTRACT Proteins play vital functional roles in essentially all biological systems, factoring into the complex expression of phenotypes and diseases observed in human populations. The quantitative study of all proteins, i.e. proteomics, has the potential to directly assess how protein dynamics vary across individuals, treatments, and exposures, ideally in an unbiased fashion not requiring pre-formed and targeted candidates. Historically a proteomics approach has been constrained due to limitations of the original mass spectrometry (MS) technology available. Transcriptomics has often been used in place of proteomics, though notably, the regulation of proteins can be decoupled from their transcripts, rendering them imperfect proxies. The feasibility of accurate and reliable proteomics has been aided by rapid advancement in MS technology. Currently the statistical tools for proteomics lag behind and present an impediment to the full use of these rich data resources. MS proteomics data possess a number of unique and challenging features that need to be addressed in their statistical analysis. Proteins are not directly measured, but instead pre-fragmented into smaller peptides. A protein's abundance must then be reconstructed from its component peptides. Complications to this process includes peptides that possess coding variants (~10% of peptides in one of our data sets), peptides that map to multiple proteins (~50%) and high levels of peptides that are unobserved in at least one of the samples (~50%). Desing features of the MS experiment, such as the use of isobaric labels, can influence the observed pattern of missing data as well as the extent of technical sources of variation, motivating the need for flexible analytical tools. To accomplish this, I will use Bayesian approaches to model MS proteomics data to flexibly incorporate multiple sources of error, as well as address these challenging features of the MS experimental procedure. The resulting statistical software will be employed on multiple large proteomics data sets from genetically diverse mouse populations that possess similar levels of genetic variability as human populations. With the improved protein abundance estimates from my software, I will then perform genetic analyses to identify novel genetic regulators of the abundance of proteins, their complexes, and their interaction networks. Specific the experimental context of each data set, I will connect these regulatory signatures to important biological processes, such as aging in the kidney and heart and glucose metabolism in pancreatic islet cells. This project will produce new statistical tools that will increase the utility of MS proteomics data and the power of downstream genetic analyses, which will be demonstrated in real data. Novel genetic regulatory relationships underlying protein dynamics and functional networks will be identified. These tools and approaches will be relevant across diverse interest groups, spanning humans, model organism systems, and various disease-focused communities.

Public health relevance
PROJECT NARRATIVE Rapid advancements in analyses of molecular “omics” data, such as RNA-seq, have increased our knowledge and understanding of the fundamental biological mechanisms underlying phenotypes and susceptibility to diseases. With improvements to mass spectrometry (MS) technologies enabling large-scale and accurate proteomics experiments, improved statistical methods that are informed by and address the unique and challenging features of MS proteomics data are necessary to fully integrate proteins into a richer synthesis of biomolecular data. I will develop statistical tools that will leverage Bayesian hierarchical approaches to more accurately model and estimate protein abundances, which I will use for downstream analyses in diverse mouse populations in order to identify novel genetic regulators of proteins and characterize dynamic protein functional networks.